Anti-inflammatory promoting commensal E. coli

DESCRIPTION (provided by applicant): The innate immune response is the first line of defense in the body's recognition of foreign molecules and, as such, plays an active role in the detection of microbial pathogens. In response, microbial pathogens have evolved intricate means to disarm this response. For example, many Gram-negative bacterial pathogens utilize specialized type 3 secretion systems to deliver tens of bacterial proteins directly into host cells proteins. These proteins, which are referred to as effectors, usurp host cell processes to promote bacterial survival. A common emerging theme is that many effectors suppress the production of pro-inflammatory cytokines by inhibiting steps in signaling pathways that lead to activation of NF-κB, a central innate immune response transcription factor. The majority of the anti-inflammatory effectors characterized to date are found in enteric pathogens, including Salmonella, Shigella, Yersinia and enteropathogenic E. coli species, bacterial, which are constantly interfacing with a variety of cell types in the gastrointestinal tract. Dysregulation ofthe innate immune system is linked to many inflammatory autoimmune-based diseases, including inflammatory bowel disease, psoriasis and rheumatoid arthritis. A major advance in the treatment of these diseases has been the development of therapeutics including TNFα inhibitors, humanized antibodies that block activity of this proinflammatory cytokine (i.e., infliximab). However, these agents, like most therapeutic modalities, are delivered systemically, which, in the case of TNFα antagonists, results in systemic immunosuppression increasing the incidence of severe infections, including tuberculosis reactivation and brain abscesses, diseases which could be prevented by targeting immunosuppression to sites of disease. Interestingly, although many gram-negative pathogens, particularly those that target the gastrointestinal tract, use specialized secretion systems to deliver proteins directly into host cells, no commensal organism of mammals has yet been identified to encode such a system. The long-term goal of this project is to develop commensal bacteria that are capable of type 3 secretion and to genetically engineer these bacteria to deliver bacterial effector proteins which specifically inhibit NF-κB activation. It is envisioned that these bacteria could be given to patients as a new means to treat inflammatory bowel disease where immunosuppression is limited to the intestines.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this work is to develop commensal bacteria as a protein delivery system for the injection of therapeutic defined proteins directly into mammalian cells located in the gastrointestinal tract. Specifically, we propose to develop bacteria that down regulate inflammation in order to reduce the symptoms and disease course associated with inflammatory bowel disease. This therapeutic paradigm has the potential to treat a variety of autoimmune-based diseases and as such would be very valuable towards improving public health. __SpecificAimsTextDelimiter__ Specific Aims The innate immune system is the first line of defense in the body's recognition of foreign molecules and, as such, plays an active role in the detection of and defense against microbial pathogens. In response, microbial pathogens have evolved intricate means to disarm this response. For example, many Gram-negative bacterial pathogens utilize specialized type 3 secretion systems to deliver tens of bacterial proteins directly into host cells. These proteins, which are referred to as effectors, usurp host cell processes to promote bacterial survival. Many effectors suppress the production of pro-inflammatory cytokines by inhibiting steps in signaling pathways that lead to activation of NF-κB, a central innate immune response transcription factor. The majority of the anti-inflammatory effectors characterized to date are found in enteric pathogens, including Salmonella, Shigella, Yersinia and enteropathogenic E. coli, bacterial species, that are constantly interfacing with a variety of cell types in the gastrointestinal tract. The host innate defense system is a vital component of the immune system, as it is required to trigger adaptive immune responses, which assist in mounting an effective response to combat infections. Notably, dysregulation of the innate immune defense system is associated with the inappropriate inflammation observed with many highly prevalent autoimmune-based diseases including inflammatory bowel disease (IBD), psoriasis and rheumatoid arthritis. Therapies targeted at suppressing inflammation by inhibiting NF-κB activity are currently being pursued as novel therapeutics for the treatment of these diseases. For example, antisense oligonucleotides directed against the p65 NF-κB subunit as well as small-molecule inhibitors of IKKβ can ameliorate disease in mouse models of intestinal inflammation. Similarly, a major advance in the treatment of patients with IBD, and other autoimmune diseases, has been the development of humanized antibodies (i.e., infliximab) that block the activity of TNFα, a proinflammatory cytokine whose expression leads to activation of NF-κB and other signaling processes. Notably, these agents, like most therapeutic modalities, are delivered systemically, which in the case of TNFα antagonists results in systemic immunosuppression increasing the incidence of these patients of severe and potentially life-threatening infections including tuberculosis reactivation and brain abscesses. Interestingly, although many Gram-negative pathogens use specialized secretion systems to deliver proteins directly into host cells, no mammalian commensal organism has yet been reported to encode such a system. We recently developed laboratory and commensal strains of E. coli that encode a functional type 3 secretion system and have engineered these bacteria to recognize heterologous proteins, both eukaryotic and prokaryotic in origin, as secreted substrates. Here, we propose to investigate the possibility of using these secretion-competent commensal E. coli strain to deliver defined therapeutic proteins directly into cells in the gastrointestinal tract. Specifically, we propose to genetically engineer the bacteria to deliver bacterial effectors that inhibit the mammalian innate immune response and to test the utility of this strain for suppressing intestinal inflammation in animal models of inflammatory bowel disease (IBD). To investigate the feasibility of this goal, we will propose the following aims: Aim 1: Develop anti-inflammatory promoting strains of Nissle 1917 E. coli. Nine type 3 secreted effectors from a variety of enteric pathogens including Shigella, Salmonella, Yersinia and enteropathogenic E. coli species target and inhibit the activity of specific host cell proteins preventing NF-κB activation, suppressing the host innate immune response. We have generated alleles of each that are recognized as substrates by our genetically engineered type 3 secretion-competent commensal Nissle 1917 E. coli strain. In this aim, we propose to identify effectors that act synergistically, or at least additively, to modulate NF-κB signaling. Aim 2: Evaluate the ability of type 3 secretion-competent strains of commensal Nissle 1917 E. coli to colonize the intestines and suppress inflammation in animal models of IBD. Nissle 1917 E. coli is a well- characterized commensal strain that can colonize the gastrointestinal tracts of humans and mice. We propose to identify conditions that enable the engineered type 3 secretion-competent variant of this strain to contact and deliver proteins into cells in the intestines. Furthermore, we will identify the specific cell types targeted as well as investigate the ability of a version of this strain that delivers anti-inflammatory effectors to suppress the intestinal inflammation observed in two complementary animal models of inflammatory bowel disease. At the completion of these two aims, we expect to have established the utility of using a commensal bacterial delivery system as a novel agent for the delivery of defined proteins with therapeutic value into cells in the gastrointestinal tract. While experiments here are focused on testing such a system for the potential treatment of inflammatory bowel disease, once developed, such a system could be further adapted to deliver defined proteins to other sites of disease.